High resolution inflammatory networks induced by HIV reservoirs in adolescents

ABSTRACT
Antiretroviral treatment (ART) for HIV infection effectively blocks viral replication, but fails to eradicate the virus,
which can be a source of persistent inflammation. The pathways by which chronic, treated HIV infection drives
inflammation are poorly defined, particularly in children and adolescents who acquire HIV perinatally. Perinatal
HIV infection occurs in the context of a developing immune system, requires life-long treatment, and even with
effective ART, treatment is associated with increased risks of metabolic, neurocognitive and cardiovascular
complications that result from this HIV-induced inflammation. Thus, to understand the mechanisms driving
inflammation in this vulnerable population that faces decades-long infection and treatment, we will study
HIV-induced inflammation in a unique cohort of perinatally infected adolescents in Kenya who have been
maintained on ART and followed clinically since their first year of life. To complement these valuable
longitudinal clinical samples, we have developed organoids of human secondary lymphoid tissues, a major HIV
reservoir site. The lymphoid organoids we are using are highly relevant to pediatric and adolescent infections
as they are derived from pediatric/adolescent tissue, contain all major immune cell types, infectable with HIV,
and are manipulable via gene editing, siRNA transfection, and antibody/small molecule inhibitors to probe
mechanisms driving HIV-induced inflammation. Our goal is to use these unique resources to identify
HIV-induced inflammatory networks in perinatally-infected adolescents on long-term ART and to define the viral
factors that drive HIV-induced inflammation. We will make use of single cell techniques, which to date have
only been applied to adult cohorts, to map the cell-intrinsic inflammatory networks induced during chronic
treated HIV infection and define the viral genes that initiate these cascades. In addition, to fill a gap that has
been missing in prior studies, we seek to understand how these rare infected cells initiate downstream
cascades of inflammation that drive pathology by studying communication networks using methods we recently
developed to infer cell-cell communication at the single cell level. This powerful combination of a long-term
pediatric treatment cohort coupled with mechanistic studies in a robust ex vivo lymphoid culture system will
provide a unique window into HIV-induced inflammation. Successful completion of this project will define
mechanisms by which residual HIV RNA expression during treated infection drives inflammation in perinatally
infected adolescents and establish models to test therapeutics.

Public health relevance
PROJECT NARRATIVE In chronically infected individuals, the latent HIV reservoir is not silent and may induce inflammation, but the pathways leading to this aberrant inflammation are poorly understood, particularly in pediatric populations who acquired HIV perinatally. The project will elucidate these pathways in perinatally-infected adolescents and mechanistically define drivers using organoid models as a step towards novel therapeutics.